Screening for small molecule degraders of KDM5A & B

During the reporting period, the collaborative team has expanded screening beyond drug repurposing libraries and identified several novel hits that have been validated by western blotting to reduce KDM5A & B protein levels in a breast cancer cell line. Additional primary screening work was conducted, and several novel chemotypes were identified demonstrating potent, selective modulation of KDM5A & B. Current efforts include hit profiling, mechanism of action studies and expanded screening of a new, novel molecular glue library.